ResearchTraining: Psychiatric and Statistical Genetics.

This application requests five further years of support for an Institutional National
Research Service Award to cover multidisciplinary training in Psychiatric, Behavioral
and Statistical Genetics. We request support for three pre-doctoral and three postdoctoral
students for primary training in: i) statistical, quantitative, behavioral and molecular
genetics; ii) psychiatric nosology; iii) neuroimaging genetics and neurobiology; iv)
clinical psychology; iv) biostatistics. In addition to specializing in one of these areas,
trainees will be exposed to all others and encouraged to study at least one other with
sufficient detail to broaden their scope for future career development and
interdisciplinary research. Training will usually be 4 years in duration for pre-doctoral
and 2-3 years for postdoctoral students. Applications are expected to continue from a
wide variety of disciplines, including medicine, psychiatry, psychology, biostatistics,
neuroscience, molecular genetics and biology.
Trainees are housed in the Virginia Institute for Psychiatric and Behavioral Genetics at
Virginia Commonwealth University, a modern custom-built facility with private offices,
state-of-the-art computational facilities, integrated molecular genetics and experimental
laboratories, and an associated neuroimaging facility. Major strengths of the program
include: i) broad expertise of faculty in psychiatry, psychology, genetics, neuroscience
and statistics; ii) highly productive research environment with well-funded faculty who
are among the most highly cited researchers in the field; iii) extensive experience and
excellent track record of faculty in training at this level; iv) potential for trainees to take
part in active data collection and data analysis projects; v) access to large genetically
informative datasets collected at VCU and elsewhere; vi) direct access to genome
sequencing, experimental study and neuroimaging facilities; vii) pairing with clinical
psychiatrist to attend rounds; and viii) face-to-face instruction in responsible conduct of
research from a leading author and instructor in this field.

Public health relevance
There is a shortage of researchers who have skills in both statistical or molecular genetics and psychiatric epidemiology. Such individuals are needed to increase our understanding of the causes and trajectories of psychiatric disorders, so that better prevention and treatments can be developed. This training grant will educate three pre-doctoral and three postdoctoral trainees in psychiatric, behavioral, statistical and molecular genetics and neuroscience.